Development and Validation of a Virtual Bariatric Endoscopic (ViBE) simulator

Development and Validation of a Virtual Bariatric Endoscopic (ViBE) Simulator
Abstract
Obesity is a chronic, relapsing, multifactorial, and neurobehavioral disease that requires life-long,
multidisciplinary management beyond a single intervention. The current treatment options for patients with
morbid obesity include pharmacotherapy, which only induces suboptimal weight loss, and bariatric surgery,
utilized only by a small fraction of the eligible patients. Endoscopic Sleeve Gastroplasty (ESG) is rapidly
emerging as a new tool to combat the obesity epidemic used both as (i) primary weight loss procedure
and (ii) endoscopic revision for patients experiencing weight gain following surgery. It is a safe and effective,
incision-less, non-surgical technique performed with a flexible endoscope, introduced through the mouth,
which reduces the gastric volume by placing full-thickness sutures from within the gastric lumen. It is a one-day
outpatient procedure with rapid return to work. However, learning to perform ESG is technically
demanding, with a minimum of 35 cases necessary to attain basic proficiency. Though endoscopic
suturing skills are critical for ESG, just learning endoscopic suturing is not sufficient for performing ESG.
With no formal curriculum or competency standards in place for ESG outside the patient-centric
apprenticeship model of medical and procedural education, it is anticipated that a virtual reality (VR)-based
trainer, with visual and haptic (touch) feedback, will be invaluable for training in ESG, allowing trainees to attain
competence in a controlled environment with no risk to patients; to enable customized learning, and to offer
real-time feedback, mentoring and objective assessment. The goal of the present proposal is to design,
develop and validate a Virtual Bariatric Endoscopic (ViBE) simulator that can be used to train
endoscopic bariatric procedures such as ESG. Significant technical innovations of this project include (1)
developing realistic physics-based real-time simulations of the ESG procedure, including an efficient
constrained spline dynamics (CSD) algorithm for modeling endoscopic suturing, (2) an innovative hardware
interface for accurate force feedback during ESG, (3) in vivo porcine experiments to characterize the
endoscopic suturing procedure; and (4) a cognitive assistant module, based on detailed cognitive task
analysis, to provide real-time feedback to the trainee. We will conduct experiments on voluntarily enrolled
participants to ensure that appropriate skills are being learned on the ViBE and performance measured on the
ViBE reflects the appropriate technical skills. Further, we will test the hypothesis that trainees who train on
the ViBE simulator will learn at the same rate or better than those trained on ex vivo porcine
gastrointestinal specimens and that this training will transfer to the clinical environment.
The significance of this project is that it focuses on the obesity epidemic and proposes to develop a
simulator to enable the safe adoption of ESG. Endoscopic suturing skills learned on the ViBE will translate to
other endoscopic procedures, e.g., stent fixation and management of bariatric surgical complications.

Public health relevance
Relevance: The goal of this research is to develop and validate a comprehensive computer-based technology that will help medical trainees to practice their skills for an emerging endoscopy-based weight loss procedure known as endoscopic sleeve gastroplasty (ESG). ESG is a nonsurgical, incision-less, organ-sparing procedure that is safe and effective and can be performed in an outpatient facilty by either a gastroenterologist or a bariatric surgeon with rapid return to work. The proposed training technology for ESG will allow clinicians to learn the procedure in a risk-free manner on computers before application to patients, resulting in improved patient outcomes and reduced treatment costs.